Project 3: Coactivator-dependent hepatic 12h clock coordinates metabolic and stress rhythms

Project 3 -­ Project Summary

In addition to the well-­studied circadian rhythm, a cluster of genes that cycle at the second (12h period) harmonic
of circadian rhythmicity was discovered in several peripheral mouse tissues in vivo. Genes exhibiting apparent
12h rhythmicity were enriched in endoplasmic reticulum (ER) stress and unfolded protein response (UPR)
pathways, which are universally conserved adaptive responses to cope with accumulation of unfolded protein in
the ER. Despite these initial findings, the exact prevalence of the 12h rhythm in vivo, its relationship with the
circadian clock, how the 12h rhythm is established at the molecular level and its precise roles in regulating both
physiology and pathology still remain elusive. We recently developed a novel mathematical approach to
decompose time-­series gene expression data and reveal hidden oscillations separate from the 24h rhythmicity.
We unexpectedly discovered that, in addition to the UPR genes, the 12h rhythmicity is much more prevalent than
was initially thought and is widely found in metabolic genes in mouse liver. We further uncovered prevalent 12h
oscillations in liver metabolism in vivo. The fact that the 12h rhythmicity remains intact in the absence of functional
24h circadian clock suggests that the 12h rhythm is established and maintained by an independent clock
component distinct from the 24h circadian clock. The objective of this proposal is to use the liver as a model
organ to test the hypothesis that: 1) there is an equally important molecular clock establishing the 12h period
rhythmicity, which coordinates oscillations of ER stress and dynamic bioenergetic metabolism to ensure systemic
homeostasis, and 2) that the hepatic 12h clock is transcriptionally regulated by SRC-­3 and XBP1s. In Aim 1 the
transcriptional regulation of the 12h rhythm of gene expression and metabolism will be investigated with a focus
on the interplay between UPR TF XBP1 and coactivator SRC-­3 using ChIP-­Seq, RNA-­Seq, metabolomics and
mathematical modeling approaches. In Aim 2, whether XBP1s/SRC-­3 dependent 12-­hour clock dysregulation
contributes to chronic ER stress-­induced NAFLD will be determined. In Aim 3, whether XBP1s/SRC-­3 dependent
12-­hour clock dysregulation contributes to nutritional challenge-­induced NAFLD will be determined.

Public health relevance
Project 3 - Project Narrative Circadian rhythm is a fundamental process that synchronizes behavioral cues with metabolic homeostasis. Disruption of diurnal cycles due to jet-lag or shift work results in severe physiological consequences including advanced aging, metabolic syndrome, and cancer. Interestingly, in addition to the 24-hour circadian rhythm, 12-hour biorhythms are also found from ancient marine species and conserved in mice and humans. The purpose of our proposed research is to define how the 12-hour rhythm is established at the molecular level and how its disruption contributes to the development and progression of metabolically related diseases. !